Diagnosis of low-grade glial tumors using 11C glutamine isotopomers

This proposal focuses on the development and validation of glutamine-derived 11C isotopomers for positron
emission tomography. Specifically, the 1- and 5-positions of exogenously administered glutamine have
different metabolic fates, depending on the dominant mechanisms of conversion present. We will therefore
synthesize both L-[1-11C]glutamine ([1-11C]gln) and L-[5-11C]glutamine ([5-11C]gln), and investigate their use in
detecting the isocitrate dehydrogenase mutation (IDHm), seen in several benign and malignant clinical
diseases including low-grade glioma (LGG). Improved diagnosis of LGG would address a major challenge that
neuro-radiologists, neuro-oncologists, radiation oncologists and neuro-surgeons encounter frequently, namely
differentiating glial tumor from other brain entities. Patients with IDH-mutant (IDHm) glioma harbor the
oncometabolite 2-hydroxyglutarate (2HG), which represents a promising way to detect LGG. We are motivated
by a recent report establishing rapid conversion of exogenous glutamine to 2HG in IDHm lesions, representing
a way to sequester the 11C radionuclide. The central hypothesis of this proposal is that a positron-
labelled metabolic precursor of 2HG, [1-11C]gln, can be used to detect IDHm. We further predict
significant advantages in using [1-11C]gln versus the reported [5-11C]gln isotopomer, based on the suppression
of background signals related to tricarboxylic acid (TCA) cycle metabolism. When validated, this approach
would set the stage for clinical use of [1-11C]gln PET in evaluating LGG and other IDHm lesions.
We propose a multi-PI and interdisciplinary collaboration to validate [1-11C]gln PET as an IDHm-specific tool
and perform the first patient studies using [1-11C]gln to further support the methodology. We will first develop
the first radiosynthesis of [1-11C]gln, via adaptation of reported methods using [11C]CO2 and [11C]CN-. We will
then compare the accumulation of [1-11C]gln to that of [5-11C]gln in IDHm versus IDH-wildtype (IDHwt) cells,
both in vitro and in vivo (Specific Aim 1). In Specific Aim 2, all regulatory work and site approvals needed to
study [1-11C]gln at UCSF will be accomplished. In Specific Aim 3, we will translate [1-11C]gln under the
Radioactive Drug Research Committee (RDRC) program and study its performance in patients suffering from
LGG. While this application focuses on LGG, a clinically translatable IDHm-specific tracer would revolutionize
the workup and management of a large variety of clinically relevant lesions. Furthermore, robust methods to
synthesize and evaluate amino-acid derived 11C isotopomers will dramatically improve the ability of PET to
detect metabolic reprogramming in human disease.

Public health relevance
PROJECT NARRATIVE: This grant application describes a way differentially label the amino acid glutamine for positron emission tomography (“PET scan”). The technology can be used to follow the metabolic fates of different positions in the molecule, potentially detecting specific enzyme mutations. The proposed technique is both simple and safe with the goal of rapid use in patients.